Promoting diversity in research training and mentoring for underrepresented minority Students (URM).

Summary
The overall objective of the R25 Research Education Program(REP) summer experience is to establish an
approach for providing minority students attending USC with the support needed to increase diversity in the field
of biomedical science and aging by providing mentorship and research training opportunities for young URM
biomedical scientists with unique experiences and perspectives. To accomplish this objective, we will: I) use our
already developed and validated innovative strategies to recruit 100 URMs to the different biomedical science
disciplines and aging related research experiences at USC. We will attract these students by conducting
seminars, workshops, and lectures at the USC campuses throughout the academic year. II) Organize a USC
Biomedical Science Forum where 50 URM students from a pool of 100 URMs will be invited for a two-day
orientation during the spring semester. These students will visit USC and its biomedical science programs while
also obtaining information on the ten-week summer REP. III) Provide a 10-week summer educational mentoring
and research opportunity at USC for ten REP students every year for five years. For the summer program, we
will,1) match each REP participant with a mentor to initiate the development of an individual development
plan(IDP), and organize a weekly mentoring activity, 2) organize professional development workshop training for
URMs in aging research, 3) implement a weekly Science/Journal club meeting to discuss publications related
to aging research, 4) organize workshop training in professional development to synergize REP students with
USC training programs in professional development activities allowing networking with other young colleagues,
and 5) provide scientific research for REP students to enhance their research career development in biomedical
sciences and promote graduate school aspirations. Beyond the summer REP, we will provide research and
mentoring opportunities to continue to synergize REP students with USC training programs. By providing
academic support initiatives, including mentoring, professional development activities and training in biomedical
science and aging related research opportunities, we will be able to increase diversity in the field of biomedical
science and aging related research for young URM biomedical scientists. Continued "mentoring " of REP students
will go on until they complete their baccalaureate degree in biomedical science and will even continue finally to
their matriculation into graduate programs in biomedical sciences at USC. We expect that 70% of REP students
in their senior years will have research experience, evident in publications (manuscripts and conference
abstracts). The research experience will prepare them for graduate programs, while the publications will make
them competitive for graduate school admission. We plan to increase awareness for at least 60% of URMs,
freshman through senior years in different career opportunities in aging research.

Public health relevance
Public Health Relevance. There is a lack of awareness in young, URM future scientists about biomedical science, aging related research and career options. This represents a threat to the future goal of creating a diversified workforce to eliminate health disparities in a rapidly aging population. Our proposed Research Education Program (REP) counters this threat in the early stages by providing early and frequent exposure to the biomedical sciences and ageing related career options through a focus on undergraduate experiences to prepare them for the graduate and healthcare workforce.